Neurocognitive responses to social threat: Links to day-to-day connectedness and suicidality in adolescent girls

ABSTRACT
In the United States, suicide is the second leading cause of death among those aged 12-17 and rates of suicide are
rising, particularly among teen girls. Critically, rates of non-fatal suicidal thoughts and behaviors (STB) among
girls are even higher. Conceptually and empirically, social processes and neural responsivity to social threat have
been linked to STB among youth. Factors related to social connectedness form the foundation of theoretical
models of STB. Yet, the mechanism by which heightened social threat responsivity confers risk for STB in girls
remains unclear. This K23 tests a model in which sustained neurocognitive responsivity to socially threatening
experiences (SNRthreat) increases STB in girls by decreasing their social connectedness. I propose that girls'
tendency to dwell on social threat disrupts their processing of positive socio-affective cues that promote
connectedness. This K23 focuses on two forms of SNRthreat: 1) enhanced representation of social threat
information in working memory and 2) perseverative thought about socially threatening experiences. A neural
index of SNRthreat will be obtained in the laboratory. Cognitive and behavioral indices will be obtained through
ambulatory assessment in daily life. Specifically, multivariate electroencephalogram (EEG) decoding will be used
to assess enhanced neural representation of social threat information in working memory, signaling sustained
internal attention to such information. Ecological momentary assessment (EMA) will be used to assess
perseverative thought about social threat in daily life, and passive ambulatory assessment will be used to index
repetitive texting about social threat. Social connectedness will also be assessed via EMA. STB, the primary
outcome, will be assessed via clinical interview at baseline, weekly via EMA, and with questionnaires at three
and six months. First, I will characterize the relation between the laboratory-based neural index and real-world
cognitive and behavioral indices of SNRthreat (Aim 1). Next, I will examine if the neural index predicts girls'
subsequent day-to-day social connectedness and longer-term differences in STB (Aim 2). Third, I will examine
if the real-world cognitive and behavioral indices predict proximal changes in girls' connectedness and STB, and
longer-term differences in STB (Aim 3). Participants will be a risk-enriched sample of 100 youth assigned female
at birth (aged 12-17). Mentor-directed training from leading experts will facilitate future investigative
independence and the development of skills in four new areas: 1) EMA, 2) passive ambulatory assessment, 3)
natural language processing, and 4) developmental neuroscience. Determining how SNRthreat is linked to social
(dis)connectedness could yield novel insights in the neurodevelopment of socio-affective processes that
contribute to STB in girls. Multi-modal research that bridges laboratory-based neural indices and real-world
responses is essential to developing targeted prevention and intervention efforts. These efforts could include
ecologically valid just-in-time interventions and those aimed at reducing SNRthreat to enhance girls' ability to
process cues that promote connectedness (e.g., a smile), in turn, reducing STB.

Public health relevance
PROJECT NARRATIVE Suicide is the second leading cause of death of youth aged 12-17, and rates of suicidal thoughts and behaviors (STB) are higher and increasing faster among adolescent girls than boys. Although the relation between socially threatening experiences and suicide-related outcomes has been well-established among adolescents, how sustained neurocognitive responses to socially threatening experiences confer risk for STB is not understood. The proposed study investigates the extent to which sustained neurocognitive responses to socially threatening experiences increases STB in adolescent girls by decreasing their feelings of social connectedness.